Defining the role of the RNA modification N6-methyladenosine during Flaviviridae virus infection

ABSTRACT
RNA modifications play diverse roles in regulating viral infection. The RNA modification N6-methyladenosine
(m6A) regulates infection by the positive-strand RNA viruses in the Flaviviridae family, through its effect on both
viral and cellular RNA. m6A regulates key aspects of RNA biology, including RNA stability, translation, and
localization, as well as interactions with m6A-binding proteins. While the basic proteins that add or bind m6A on
mRNA are known, little is known about how the m6A-methyltransferase complex or m6A-binding proteins are
specifically regulated or targeted to viral and cellular RNA during infection. Our previous work has revealed that
the RNA genomes of viruses in the Flaviviridae family are m6A-modified at specific sites, and that m6A at one
site in the hepatitis C virus (HCV) genome negatively regulates infectious particle production by inhibiting
interaction of the HCV RNA genome with the viral packaging protein. We also found that Flaviviridae-induced
cellular signaling pathways alter m6A changes in host mRNAs important for infection. Finally, our preliminary
data identify novel m6A-methyltransferase interacting proteins and a novel m6A-reader with a described role in
the antiviral interferon (IFN) response. The goal of this proposal is to elucidate the molecular mechanisms of
how m6A-targeting to viral and cellular RNA regulates infection by specific viruses in the Flaviviridae family.
Based on our preliminary data, the central hypothesis of this proposal is that the specific m6A regulatory pathways
co-opted and induced by viral infection can be determinants of viral replication. Guided by our preliminary data,
this hypothesis will be tested by pursuing the following three specific aims: 1) Define how the m6A-
methyltransferase complex targets HCV RNA to regulate infection; 2) Determine how Flaviviridae infection alters
m6A regulation of specific host mRNAs; 3) Characterize an IFN-induced m6A-reader that restricts Flaviviridae
infection. In Aim 1, we will define how the nuclear m6A-methyltransferase is recruited to the cytoplasmic-localized
RNA genome of HCV. In Aim 2, we will investigate how the m6A-methyltransferase complex is functionalized
during viral infection to differentially target cellular mRNAs for methylation. In Aim 3, we will define the molecular
determinants of how an IFN-induced m6A reader targets viral and host m6A-modified RNA to inhibit Flaviviridae
infection. The proposed work will be significant and innovative because it will define cellular pathways and
mechanisms that alter m6A-methyltransferase composition and function during Flaviviridae infection, as well as
define new IFN-induced regulators of m6A, thus uncovering new host pathways exploited by viruses or utilized
by the host to inhibit infection. Importantly, this work will also reveal novel aspects of how gene expression is
regulated by m6A, including the fact that specific cellular signaling pathways alter how m6A is placed on specific
mRNAs. Thus, this work has broad implications for understanding a host of human diseases that are caused by
altered gene expression and regulated by RNA modifications.

Public health relevance
PROJECT NARRATIVE RNA viruses, such as hepatitis C virus (HCV) and dengue virus (DENV), encompass both established and emerging pathogens, and cause significant morbidity and mortality worldwide remaining a constant threat to global public health. The proposed study will define new host pathways exploited by RNA viruses such as HCV and DENV that could form the basis of new antiviral therapies to limit viral infection. In addition, it will describe new mechanisms of regulation of the RNA modification m6A that will enable new understanding into a host of human diseases that are caused by altered gene expression and regulated by RNA modifications.